Mechanisms of cell non-autonomous signaling through the hypoxic response

Project Summary/Abstract
Led by groundbreaking studies in invertebrate models, our understanding of the mechanisms of aging has
grown exponentially in the past 25 years. Despite this growth, there are many aspects of the genetic and
molecular mechanisms of aging that are still not well understood. One of these mechanisms is the ability of
small subsets of cells (frequently neurons) to modulate the aging process cell non-autonomously. Recently,
multiple high-impact publications have identified individual genes and neurons that initiate signaling pathways
and eventually modify the physiology of peripheral tissues to benefit health and longevity. These studies
provide substantial evidence that cell non-autonomous control of aging is common to multiple longevity
pathways, but they lack in detail as to the specific signals, receptors, and neural circuits involved. Our
preliminary data identify a new cell non-autonomous longevity pathway, led by the transcription factor
necessary to respond to low oxygen environments, the hypoxia-inducible factor (hif-1). We further find that
stabilization of HIF-1 in neurons, through either genetic or environmental approaches, leads to induction of an
intestinal protein, flavin-containing monooxygenase-2 (fmo-2), that is both necessary and sufficient to improve
healthspan, stress resistance, and longevity. We observe that induction of fmo-2 and extension of lifespan by
HIF-1 stabilization each depend on the presence of the serotonin producing enzyme tph-1 and the serotonin
receptor ser-7. This project will map core neural components of the cell non-autonomous pathway initiated by
stabilization of neuronal HIF-1 that eventually leads to intestinal fmo-2 induction and extension of lifespan. Aim
1 will focus on the initiation of the response, including the identity of the neurons and the timing and
mechanism of HIF-1's promotion of physiological changes cell non-autonomously. The results will establish
where and how a small subset of neurons initiates a broad response to low oxygen. The second aim focuses
on the neuron expressing ser-7, a highly conserved serotonin receptor that propagates the HIF-1-mediated
signal. The third aim will focus on the neural circuit downstream of HIF-1, identifying key propagating and
integrating cells and core signals both unique to this pathway and shared by other cell non-autonomous
networks. The results will define a neural circuit led by HIF-1 and utilizing serotonin that may partially overlap
with other longevity pathways. The resulting data are crucial to our understanding of defined networks that
control physiology and the rate of aging, and will likely lead to future studies designed to mimic signals in these
networks. Together, these aims will act independently and synergistically to provide an understanding of a
major signaling network that modifies aging. Our ultimate goal is to exploit this knowledge of control
mechanisms of aging to develop approaches that promote human health.

Public health relevance
Project Narrative. Recent studies show that the aging process is frequently modified by signals originating in the nervous system. This project will map one of these signaling pathways, derived from the response to low oxygen and utilizing the well-studied signaling molecule, serotonin, in the nematode Caenorhabditis elegans. The resulting data will provide insights and develop a model that will aid in advancing techniques to exploit neural signaling in the treatment of diseases of aging.